Mechanisms of JAG1-mediated immune suppression in the pancreatic cancer microenvironment

Pancreatic cancer (PanCan) is notorious for its resistance to therapy including immunotherapy,
which is largely contributed by a suppressive tumor microenvironment. Targeting molecular
pathways integral to PanCan resistance to current therapy remains an unmet need. Notch
signaling regulates PanCan growth, metastasis, and the tumor microenvironment. While other
studies have shown that Notch signaling in macrophage and myeloid derived suppressor cells
plays an immune-suppressive role in breast cancer and lung cancer, for example, our proposal
will study previously unrecognized role of JAG1 in the regulation of the metabolic fitness of
conventional dendritic cells (cDCs) that underlies the poor anti-tumor responses to
immunotherapy. The overarching objective of this application is to define if targeting Jagged1
(JAG1), a Notch ligand, whose expression correlates with a worse prognosis and inversely
correlates with BATF3, essential for type I cDC (cDC1) development, could reverse the
immunotherapy resistance in tumors with poor tumor-infiltrating cDC1 and T cells. cDC1 cells
present tumor antigens to tumor-killing T cells and thus play a critical role in supporting T cell anti-
tumor immunity in immunotherapy. However, dendritic cells are present in low numbers and often
display functional suppression in pancreatic cancer patients. Our recent work revealed that JAG1
functions as an inhibitory Notch ligand for cDC1 development as well as cDC metabolic fitness.
We also found that ablating JAG1 induced marked tumor regression and prolonged tumor-bearing
mice long-term survival by increasing and reviving tumor-infiltrating DCs and Notch-activated
tumor-killing T cells. We will test our central hypothesis that JAG1 promotes PanCan therapy
resistance by suppressing cDC1 metabolic fitness and CD8 T cell anti-tumor response through
three interrelated aims. In aim 1, we will test if anti-JAG1 blocking antibody could sensitize
resistant tumors to immunotherapy. In aim 2, we will investigate the mechanism by which JAG1
impairs cDC metabolic fitness essential for anti-tumor activation. Aim 3 will focus on the
mechanism of anti-tumor T cell reinvigoration mediated by JAG1 ablation/blockade. We will use
a combination of the autochthonous KPC mouse model, immunophenotypically defined KPC
orthotopic tumors, human PanCan organoids/myeloid cell coculture, and human PanCan
specimens. We will employ cutting-edge mass cytometry to investigate the interplay between
tumor cells and the surrounding immune cells and the tumor stroma. We will integrate the
immunophenotyping and the spatial transcriptomics of rare immune cell populations with clinical
and histopathological information to correlate molecular findings with patient outcomes. This work
is innovative as we illuminate a novel function of JAG1 in the maintenance of PanCan therapy
resistance and explore its potential as a novel immunomodulatory treatment for this deadly
disease.

Public health relevance
Targeting signals integral to pancreatic cancer suppressive tumor microenvironment (TME) is an unmet need and an essential goal for achieving complete and durable responses to current therapy including immunotherapy. Here, we investigate a novel mechanism by which JAG1, a pancreatic cancer worse prognostic marker, regulates the suppressive TME by impairing the anti-tumor immune response of immune cell infiltration, metabolic fitness, and function. The overarching goal of this study is to test if targeting JAG1 could overcome pancreatic cancer immunotherapy-resistance and to reinvigorate anti-tumor response.